ReproNim: A Center for Reproducible Neuroimaging Computation

SUMMARY: Curbing irreproducibility and increasing efficiency and efficacy in research disciplines relying on
brain imaging requires not only new technologies and tools, but also a strong component of community
engagement and training. During the first phase (2016-2020) the ReproNim training core has developed and
disseminated educational material for reproducible neuroimaging through four in-person workshops and a
series of training activities timed with the OHBM, SfN, and NeuroInformatics conferences. We have also
developed a Massively Online Open course (MOOC) on the Moodle platform to widely disseminate our training
material, and have launched the “Train the Trainer” fellowship program in partnership with the International
Neuroinformatics Coordinating Facility (INCF). Most ReproNim Fellows (18 out of 21) reported they are
organizing training events; to date Fellows alone have trained well over 500 trainees . During this first phase,
we also learned which activities were the most efficient in disseminating ReproNim training. In the next phase,
we propose to extend and complement our previous work in three directions. First, we will develop more
comprehensive material, adapted to different trainee backgrounds. We will use specific common key user
stories to develop materials that will demonstrate how these can be answered with the combined use of the
ReproTools. Second, acknowledging that with limited resources we cannot only rely on training everyone
through our own workshops, we will be working on scalable solutions to training by 1) rolling out a more
complete version of our MOOC, and 2) extending our Train the Trainer fellowship program to operate a
pyramid scheme, such that our Fellows not only develop educational programs in their local environs, but
leverage the Train-the-Trainer materials to conduct their own Trainer programs. Third, as materials are being
constantly developed in a distributed manner and need to be up-to-date, we will implement better findability
and accessibility to updated training material through the development of an inventory of annotated links to
training resources. While working on these goals, we will be building a community of trainees and (future)
trainers able to participate in the development, dissemination and use of reproducible neuroimaging research
practices and tools.

Public health relevance
Project Narrative A large investment in time and money is made to support neuroimaging research to understand how brain structure and function develops and ages, and how various disorders affect it. However, much of this research, while very valuable, is performed on a relatively small number of subjects and is reported in a way that makes it difficult to replicate or assess its generalization across the population. ReproNim: A Center for Reproducible Neuroimaging Computation, provides a re-executable framework for capturing data and performing neuroimaging analysis. In this renewal, we seek to improve the efficiency of this framework in support of improving all clinical and research studies using neuroimaging.